Explore hepatitis B virus preS2 mutants as immune escape mutants

ABSTRACT
Chronic infection with hepatitis B virus (HBV) is a leading cause of liver cancer. HBV produces
co-terminal large (L), middle (M), and small (S) envelope proteins containing preS1+preS2+S, preS2+S,
and S domain alone, respectively. Central S domain and N-terminal preS1 domain respectively mediate
virion attachment to HSPG and NTCP, the low- and high-affinity HBV receptors. Corresponding
antibodies can neutralize HBV infectivity, although how anti-preS2 antibodies neutralize HBV infectivity
remains enigmatic. Intriguingly, preventing M protein expression or artificially deleting most part of the
preS2 domain does not impair HBV virion production or viral infectivity in cell culture, and late stage of
chronic HBV infection often selects for point mutation of preS2 ATG codon to abolish M protein
expression, or in-frame deletions to remove N-terminal preS2 domain. Such deletions are much more
prevalent in liver cancer patients than those with mild liver diseases, but the driving force remains unclear.
This R21 exploratory grant application aims to characterize the biological properties of such naturally
occurring and clinically important HBV mutants. We hypothesize that 1) M-minus mutants and preS2
deletion mutants remain infectious; 2) preS2 deletions escape neutralization by anti-preS2 antibodies,
which can work through binding to preS2 domain on either L or M protein; 3) consequently M-minus
mutants partially escape anti-preS2 antibodies. Two specific aims are proposed to critically test our
working hypotheses. Aim 1 will characterize clinically important M-minus and preS2 deletion mutants
and establish their infectivity. The naturally occurring mutations will be introduced to an infectious clone
of genotype C and genotype D, respectively, and viral particles generated from transfected HepG2 cells
will be inoculated to HepG2/NTCP cells and differentiated HepaRG cells to test their infectivity. Aim 2
will determine susceptibility of such M-minus and preS2 deletion mutants to neutralizing antibodies and
establish whether anti-preS2 antibodies work through L, M, or either protein. We will abolish M protein
expression by mutation of preS2 ATG codon and enhance its expression via optimized Kozak sequence.
In addition, viral particles containing neutralization escaping preS2 deletion in L, M, or both proteins will
be generated by co-transfection experiments and their susceptibility to anti-preS2 antibodies determined.
If the proposed studies reveal that anti-preS2 antibodies can neutralize HBV infectivity through M protein,
then an additional host factor might be involved in infection by wild-type HBV. In this regard polymerized
human serum albumin can bind to the preS2 domain on M protein, which was proposed over 30 years
ago as an HBV entry mechanism.

Public health relevance
Project narrative Both large and middle envelope proteins of hepatitis B virus contain the preS2 domain, and late stage of chronic infection often selects for deletions to remove part of the preS2 domain. We will perform transfection and infection experiments in cell culture to critically test our hypothesis that such deletions escape neutralizing antibodies, which block viral infection by binding to either large or middle envelope protein. If proven, immune escape could explain the selection of such deletion mutants and their close association with liver cancer development.